BCM/TSU P20 Collaborative Union for Cancer Research, Education and Disparities (CURED) Administrative Core (AC)

ABSTRACT – CURED Administrative Core
Administrative Core of the proposed BCM-TSU P20 CURED program will serve as a primary administrative unit
that oversees the collaborative research, education and associated outreach efforts between the two institutions.
The goal of Administrative Core is to ensure continuity of the strong and productive ongoing partnership between
BCM and TSU to enhance cancer research and education capacity at both BCM and TSU while promoting the
diversity of the cancer research workforce. This is to be accomplished through activities such as administrative
oversight, operational support, communications, as well as regulatory and financial oversight. The two objectives
of Administrative Core are: (1) To provide integrated administrative support, promote recruitment and increase
diversity: The pilot projects and cores will benefit from centralized activities regarding budgetary activity, including
dispensing monies, overseeing budgets, generating interim and final financial reports and resolving disputes. In
addition, the administrative core with input from the IAC will use the discretionary funds it receives each year to
support new pilot projects in both institutions. It will collaborate with the Education core (C-REP) to promote
sustainable cancer research and education capacity in P20 program. It will also facilitate C-REP to develop
systematic curriculum and educational research programs between the institutions. It will conduct planning and
evaluation of the P20 partnership, ensure the partnership follows NIH policies and guidelines and submit the
annual financial and scientific reports to the IAC, EAC and NIH. (2) To provide scientific oversight and promote
collaborations: The core will provide scientific oversight by arranging internal meetings of investigators,
assessing research progress, and providing project management support to ensure that milestones are
accomplished in a timely manner. It will also coordinate internal and external advisory committee meetings and
implement the recommendations received. It will ensure frequent interactions and promote collaborations
between members of both the institutions by conducting regular seminars and monthly meetings. It will work with
institutional leaders to promote recruitment of new workforce to ensure diversity, equity and inclusion (DEI). We
expect this BCU-TSU P20 CURED program will evolve to be a highly collaborative, systematic and sustainable
partnership between the two institutions that synergizes strengths of faculty and students in cancer research,
education and community outreach.

Public health relevance
NARRATIVE – CURED Administrative Core The goal of the Administrative Core in the BCM-TSU P20 Collaborative Union for Cancer Research, Education and Disparities (BCM-TSU P20 CURED) program will be to ensure continuity of the strong and productive ongoing partnership between BCM and TSU enhance cancer research and education capacity at both BCM and TSU while promoting the diversity of the cancer research workforce. The CURED proposes to not only provide integrated administrative support, promote recruitment and increase diversity, but also provide scientific oversight and promote sustainable collaborations in the areas of research, education and community outreach.